Regulated cell death and responses to starvation in cancer

Abstract
Cells respond to stress by upregulating adaptive mechanisms that promote survival or by
undergoing cell death when the stress is too severe. Cancer cells take advantage of stress
responses in order to survive within harsh cancer microenvironments, and understanding which
adaptive mechanisms are utilized to avoid cell death is critical to gaining new knowledge that may
be exploited for cancer therapy. It has also become clear that there is not one, but in fact many
different forms of cell death that can occur in response to stress, and our studies have contributed
significantly in this area. We have shown that some mechanisms have unique effects on the
dynamics of cell populations, and that some promote, while others may hinder, therapeutic
responses. Our proposed research program will focus on two major areas of discovery: (1) How
is cell death regulated in response to stress, and how do particular mechanisms contribute to
controlling population dynamics? (2) How do cells respond to nutrient starvation through adaptive
mechanisms that involve lysosomes? We will exploit recent findings and methods we have
developed to study these overarching questions through an integrated set of cell biological
approaches with a focus on imaging-based studies.

Public health relevance
Narrative When cells are stressed they can adapt and try to survive, or they can instead undergo cell death if the stress is too severe. Cancer cells tip this balance by finding ways to survive when normal cells might typically die. Our research has contributed significant new knowledge by uncovering mechanisms of cell death and new cellular adaptations that promote cell survival, uncovering vulnerabilities that can be targeted for cancer therapy.